Mayo Center for Cell Signaling in Gastroenterology

PROJECT SUMMARY
The overall objective of the Mayo Clinic Center for Cell Signaling in Gastroenterology (C-SiG) is to improve
the health of patients with digestive diseases. We do this by facilitating discovery-translation-application
paradigms driven by mechanistic insights, cell signaling pathways, cellular networks, and spatial biology of
gastrointestinal tissue. C-SiG provides a robust infrastructure supporting technological advances, thematic
platforms, and career development opportunities leading to the integration of diverse expertise and impactful
discovery and translational science. Our Research Base consists of 59 scientists (16% increase since the
center was founded in 2009) involving 15 departments/divisions and $22 million direct costs (64%
growth since center was founded in 2009) in digestive diseases-related funding (47% from NIDDK).
Responding to members’ evolving interests and scientific advances, we’ve realigned members into three
interconnected Mechanistic Research Themes (cellular networks, intracellular signaling, and
genetics/epigenetics), each intersecting with three Disease Focus Groups (liver pathobiology,
dysmotility/metabolism, inflammation/transformation), a matrix that fosters both discovery and disease
relevant investigation. Our ongoing CENTRAL HYPOTHESIS is that advances in care of patients with
digestive diseases requires a facilitative infrastructure supporting meaningful interactions among
multidisciplinary scientists investigating cellular mechanisms, pathways, and therapeutic targets to enhance
rapid translation of basic discoveries into clinical trials. Our OVERALL SPECIFIC AIMS are to: i) Foster
multidisciplinary research by integrating a diverse group of clinical and basic science investigators in a team-
based approach to advancing knowledge and technical capabilities; ii) Offer access to cutting-edge,
specialized technologies, resources and skilled technical expertise through core services (Microscopy and
Microfluidics, Epigenomics and Spatial Biology, and Clinical Cores), with continually evolving service
options and quality and project management oversight in response to member feedback; iii) Create
opportunities to engage and nurture new GI investigators via a peer-reviewed Pilot and Feasibility (P/F)
Program including structured mentorship, career development retreats, curricula, and structured (30/42, 71%
of P/F recipients achieving federal funding); iv) Support a robust Enrichment Program facilitating
collaboration and technology transfer; and v) Promote interactions between C-SiG with Mayo institutional
partners (e.g., Center for Individualized Medicine) and existing DDRCCs, especially in the Midwest (i.e.,
Midwest DDRCC Alliance). Our global efforts have resulted in 160 manuscripts, with 46% percent intra-
and 54% inter-thematic publications (77% involving ≥ 2 members). Importantly, we’ve made critical
advances in understanding disease pathogenesis relevant to cellular networks, signal transduction, and
genetics/epigenetics as evident by the academic and translational achievements of our research base.

Public health relevance
PROJECT NARRATIVE Gastrointestinal diseases and their complications have a significant negative effect on public health and incur considerable health care utilization costs. Research supported by this Center grant is critically important to advance our understanding of the mechanisms that underlie digestive diseases. This new knowledge can lead to practical applications for the diagnosis, prevention, monitoring, and treatment of digestive diseases.